Mechanisms of asymmetric cell division during female meiosis

Project Summary
During female meiosis, ¾ of the chromosomes are eliminated and only ¼ of the
chromosomes are inherited by a single egg. In contrast, all chromosomes are
distributed among 4 sperm during male meiosis. The elimination of ¾ of the genome to
allow inheritance of only ¼ of the chromosomes is conserved in all animal phyla,
suggesting some fundamental selective advantage. The long-term goals of this project
are to elucidate the molecular mechanisms of chromosome elimination and elucidate the
selective advantages of asymmetric meiotic division. Errors in meiosis lead to the
absence of one chromosome (monosomy) or the presence of an extra chromosome
(trisomy) in 10-30% of human conceptions with the majority of these aneuploidies
leading to embryonic death. By elucidating the mechanisms of meiotic chromosome
elimination in C. elegans, we will identify mechanisms likely to be defective during
human meiosis. Fertilization occurs during female meiosis in nearly all animal species.
Therefore, animals must have mechanisms to prevent incorporation of paternal
chromosomes into the meiotic spindle which could eliminate paternal chromosomes in a
polar body causing lethal monosomy. We have demonstrated that, in C. elegans,
microtubule driven transport moves the meiotic spindle to a cortical position away from
the future site of fertilization. The meiotic spindle resists cytoplasmic streaming whereas
the sperm contents circulate as a cohesive unit with maternal membranous organelles
around the zygote. Increasing cytoplasmic streaming causes collisions between the
spindle and sperm contents, however, the resulting collisions do not result in
incorporation of paternal chromosomes into the meiotic spindle. We seek to elucidate
the completely unexplored mechanism that holds the sperm contents together as this
“goo ball” insulates paternal chromosomes from capture into the meiotic spindle. We
have uncovered a second selective advantage of asymmetric meiosis by demonstrating
that extra chromosomes present in trisomic or triploid C. elegans are preferentially
deposited in a polar body. We seek to determine the mechanisms that preferentially
move extra chromosomes toward the polar body. These mechanisms allow triploid or
aneuploid C. elegans to have a high frequency of offspring with a normal chromosome
number and could be relevant to the health prospects for offspring of women with triploX
syndrome, trisomy 21 or mosaic trisomy. In addition, we will continue to elucidate the
katanin, kinesin and dynein-dependent mechanisms ensuring bipolar meiotic spindle
assembly and positioning. We will accomplish these goals by directly monitoring the
movements of chromosomes and organelles by time-lapse imaging of zygotes observed
in utero within transparent C. elegans after perturbations by RNA interference, auxin-
induced degrons and optogenetic manipulations.

Public health relevance
Project Narrative The proposed research is relevant to public health because chromosomes are missing or an extra chromosome is present in 10-30% of human conceptions. The majority of these chromosomal abnormalities are caused by defects during female meiosis and these chromosomal abnormalities lead to embryonic death or cognitive disability. The proposed research will reveal mechanisms that may cause these abnormalities in humans and will suggest ways to prevent them.